Accurate Molecular Decision Making during Protein Biogenesis

Project Summary: Accurate Molecular Decision Making during Protein Biogenesis
Accurate protein biogenesis is a pre-requisite for the generation and maintenance of a
functional proteome and, by extension, for human health. Our long-term goal is to understand
the molecular mechanisms by which diverse protein biogenesis pathways in the cell accurately
select nascent protein substrates and ensure their correct folding, localization, maturation, and
quality control. Three major components define our research program in the next grant cycle.
Firstly, we will define how nascent proteins acquire the correct set of chemical modifications
during translation, which play essential roles in the maturation, localization, and stability of the
proteome. These studies will include N-terminal methionine excision by methionine
aminopeptidases, protein acetylation by multiple classes of N-acetyltransferases, and protein
acylation by N-terminal myristoyltransferases. In addition to establishing the cotranslational
mechanisms of these essential enzymes for the first time, these enzymes will provide a case
study for how diverse protein biogenesis machineries gain timely and selective access to the
nascent proteome in the crowded environment of the ribosome exit site.
Secondly, we will decipher how cotranslational chaperones guide nascent proteins through the
most productive biogenesis pathways. We will focus on two goals: (i) Test the role of the
nascent polypeptide-associated complex (NAC) as a master regulator of diverse cotranslational
protein biogenesis machineries; and (ii) Decipher the mechanism by which the ribosome-
associated complex (RAC) together with Hsp70 facilitate cotranslational protein folding. These
studies will establish a new model to understand the spatiotemporal coordination of diverse
protein biogenesis pathways at the ribosome and probe the mechanisms by which the Hsp70
machinery cooperates with the translating ribosome to reshape the folding trajectory of nascent
proteins.
Thirdly, we will probe the mechanism of mitochondrial biogenesis and protein quality control.
We will use selective ribosome profiling to uncover and understand cotranslational protein
targeting to mitochondria. We will decipher the molecular mechanism of the recently discovered
AAA+ chaperone Skd3, which displays multiple distinct chaperone activities that may be
particularly suited to its role as the only general chaperone in the mitochondrial intermembrane
space (IMS). These studies will address long-standing questions about protein targeting to
mitochondria and protein folding in the mitochondrial IMS and provide insights into the
molecular principles governing these processes.
The proposed research will not only generate high-resolution understandings of many protein
biogenesis pathways, but also establish valuable conceptual frameworks to understand how
nascent proteins are accurately selected into their appropriate biogenesis pathways in the
crowded cytosolic environment.

Public health relevance
Project Narrative Accurate protein biogenesis is a pre-requisite for the generation and maintenance of a functional proteome, and is critical for preventing the onset of numerous diseases rooted in defective protein homeostasis. The proposed studies will advance our knowledge of the molecular and cellular mechanisms that ensure protein homeostasis within the cell, and contribute to the general understanding of physiology and pathology of eukaryotic cells at a fundamental level.